Development and validation of novel mouse models and expression vectors for characterizing severe alpha-thalassemia pathophysiology and evaluating gene therapy approaches.

ABSTRACT
a-Thalassemia (a-thal) is caused by insufficient production of the a-globin protein due to either deletional or non-
deletional mutations of endogenous a-globin genes. In patients with severe a-thal (no or minimal synthesis of a-
globin chains), a blood transfusion independent-state is achievable through allogeneic bone marrow
transplantation, but this approach is limited to only some patients and is plagued by potential serious adverse
effects, such as graft rejection or graft-versus-host disease. No mouse models of severe a-thal are available to
study this disease and to test new therapies. Our proposed work will address these knowledge gaps by
developing, characterizing, and validating mouse models and gene therapy vectors for treating severe a-thal.
We hypothesize that new mouse models of a-thal will define the basic mechanism that governs RBC synthesis
in the presence of excess ß-globin chains and how it affects erythropoiesis, iron metabolism and coagulation. In
our first aim we will characterize these features in novel mouse models of severe a-thalassemia. As preliminary
studies, we generated adult animals that do not produce a-globin chains (AG-KO) through transplantation of both
AG-KO fetal liver and conditional AG-cKO hematopoietic stem cells into wild-type recipient mice. These animals
demonstrate a worsening phenotype, with red blood cells (RBC) that express only b-globin chains. Due to severe
limitation of these RBC to deliver oxygen, the mice eventually succumb to a condition resembling hypoxemia,
showing splenomegaly, liver and kidney iron deposition, and vaso-occlusive events. We are now generating
animals that only express one copy of the a-globin gene to characterize this disease in the context of minimal
synthesis of a-globin chains. Most of the patients affected by a-thal carry large deletions of the a-globin genes.
These deletions represent a serious challenge for gene therapy approaches based on genome editing.
Therefore, we hypothesize that severe a-thal can be safely rescued by gene addition. In our second aim we will
fully validate lentiviral vectors carrying the a-globin gene for their safety and ability to reverse the most severe
forms of a-thal. We identified ALS20aI, in which a-globin is under control of the ß-globin promoter and its locus
control region, as the most efficient vector. One copy of ALS20αI yields exogenous a-globin at a level
comparable to that produced by one endogenous a-globin gene. Indeed, ALS20aI rescues animals generated
with AG-KO fetal liver or conditional AG-cKO hematopoietic stem cells, suggesting that a relatively low vector
copy number could result in dramatic therapeutic benefits. We will test ALS20aI or its derivatives for their ability
to express the safest and highest level of a-globin in mouse hematopoietic stem cells and human-derived
erythroid cell lines that synthesize low or no a-globin chains. We will then evaluate the constructs for their ability
to rescue the abnormal features observed in a-thal patient cells. Thus, the goals of this study are to develop
novel adult mouse models of a-thal and an effective gene therapy approach for this disease.

Public health relevance
PROJECT NARRATIVE There are many patients of a-thalassemia, current therapies are insufficient for many of them and there are very few studies on a-thalassemia; in addition, no severe mouse models are available to study this disease and to test new therapies. Our goals are to generate new mouse models to investigate this understudied disease and to test if a newly generated lentiviral vector that expresses the human a-globin gene can correct mice affected by severe forms of a-thalassemia. Our proposed work will address these knowledge gaps by developing, characterizing, and validating mouse models and gene therapy vectors for treating severe a-thalassemia.